Assessing Alzheimer disease risk and heterogeneity using multimodal machine learning approaches

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is the most common form of dementia characterized by progressive loss of cognitive
function. Unfortunately, currently there is no effective treatment for AD and clinical interventions of AD have
largely failed despite enormous efforts. For the current application, we seek to develop multimodal machine
learning models by leveraging the rich collection of AD-related omics data and phenotypical data recently
generated from large-scale collaborative projects such as Alzheimer Disease Neuroimaging Initiative (ADNI),
Accelerating Medicines Partnership-AD (AMP-AD) and the Alzheimer's Disease Sequencing Project (ADSP).
Three aims will be pursued in the current application. Aim 1. We will build an expandable multimodal
unsupervised machine learning framework to investigate AD heterogeneity. Given the multifactorial nature of
AD, we will perform AD subtyping by harnessing the rich information across multiple spectrum of data. Aim 2.
We will build an expandable multimodal supervised machine learning framework to quantify AD risk from
longitudinal follow up of cognitively normal elders. The models will be built from genetic susceptibility and gene
regulatory information as well as endophenotypes measured when participants were cognitive normal. Aim 3.
We will build AD-related gene interaction networks in post-mortem human brain samples. We will examine the
association of multiple omics data with AD in brain samples, and build tissue-specific interaction networks to
understand potential molecular mechanisms underlying AD pathogenesis. The present application represents
an innovative approach to identify individuals at high risk of AD from both clinical and genetic risk factors in
ethnically diverse populations. The outlined strategy will provide new insights into the risk stratification and
prevention strategies for AD. We also commit to share our methods through GitHub or CRAN for free access
across the scientific community.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is the most common form of dementia but therapeutic clinical trials for AD have largely failed. The objective of our proposal is to develop and apply multimodal machine learning methods that can identify patterns and/or clusters with similar characteristics using extremely large amounts of data such as have been generated by the Alzheimer's Disease Sequencing Project (ADSP) and other large-scale collaborative projects. We will apply these methodsto investigate AD heterogeneity and identify people with high AD risk before symptoms are observed, which might provide new avenues for better diagnosis and treatment of AD.